Promoting Increases in Living Organ Donation via Tele-navigation (PILOT)

SUMMARY
The demand for kidney transplantation continues to greatly exceed the supply, and living kidney donors remain
a critical source of organs for their loved ones. Living donor kidney transplantation (LDKT) has decreased in
the US since 2004, and importantly, significant geographic disparities in likelihood of LDKT have been
identified, with the southeastern US having the lowest rates. Transplant candidate-related and potential living
donor-related factors, including difficulty asking family/friends to donate on one’s behalf and lack of knowledge
about the donation process, respectively, have been implicated in lower donation rates. Programs have been
developed to separate the advocacy role from the transplant candidate in order to overcome barriers
associated with asking someone to donate on one’s behalf, and have demonstrated increases in living donor
inquiries. Importantly, these programs were developed and implemented in resource-intense urban settings
that afforded ready access to high-speed internet, cell phone service and close geographic proximity to urban-
based transplant centers, limiting their generalizability to low-resource settings like the rural, southeastern US.
Moreover, these programs failed to include targeted interventions to improve potential living donor comfort with
the evaluation process, impeding sustained increases in LDKT. Living donor selection is a comprehensive
process that begins with potential donor inquiry, screening of potential donors for absolute contraindications to
donation (e.g. solitary kidney), evaluation, and ultimately approval. This process is time-consuming,
overwhelming, and involves complex and frequent interactions with the healthcare system. Not surprisingly,
many potential living donors withdraw from the process prior to approval and donation. Multiple studies have
demonstrated the feasibility and efficacy of patient navigator programs in improving outcomes, including more
efficient use of healthcare systems. In order to address knowledge gaps within existing programs designed to
increase living donation, we utilized the RE-AIM framework to develop and implement a novel Living Donor
Navigator Program (LDN). LDN combines advocacy-training to overcome barriers in initiating conversations
with and identification of potential living donors with the use of non-clinical navigators to guide donors through
the evaluation process. Early results indicate a 7-fold increase in likelihood of an approved donor among LDN
participants compared to non-participants; however, assessment of LDN reach and adoption demonstrated
that geographic disparities among participants exist. We hypothesize that expansion of the LDN program to
include telehealth delivery will overcome geographic disparities in access and facilitate sustained increases in
living donation. To this end, we will address the following aims: 1) Conduct qualitative assessments to identify
facilitators for LDN telehealth participation, 2) Implement a LDN telehealth program, and 3) Compare the
effectiveness of telehealth LDN model vs. standard of care for increasing living kidney donation.

Public health relevance
NARRATIVE Living kidney donors remain a critical source of organs for their loved ones; yet LDKT has decreased substantially since 2004 particularly in the southeastern US. Existing organ donation educational programs have focused primarily on addressing transplant-candidate factors by separating the advocacy role from the candidates; however, these programs have failed to address potential donor concerns regarding comfort with the evaluation process and have relied on resource intense education aides, which are often not readily available in many under resourced, often rural, areas of the southeastern US. It is critical to develop programs that will ensure sustainable increases in living donation independent of geography.